Function of the IRF5 risk allele for SLE in B cells

? DESCRIPTION (provided by applicant): The systemic lupus erythematosus susceptibility allele of IRF5 exhibits increased expression in myeloid cells and contributes to the interferon signature. This is a proposal to investigate the expression and functionality of the susceptibility allele in B cells. We hypothesize that the susceptibility allele enhances transitional B cell survival and mature B cell responsiveness to antigen. Most importantly, we propose that the susceptibility allele exhibits increased responsiveness to estrogen in synergy with type 1 interferon. We will explore these hypotheses studying primary B cells from healthy risk allele positive and negative individuals.

Public health relevance
PUBLIC HEALTH RELEVANCE: This is a proposal to understand the impact of a lupus susceptibility gene, IRF5, on B cell function. In particular, we determine whether, the impact of estrogen and interferon on B cells is mediated through IRF5 and specifically, whether the effects of these agents are enhanced when the IRF5 susceptibility allele is present.